IGF::CL::IGF:INFINITY CONFERENCE GROUP INC:1108883 [17-007500]Conference planning and administrative services for the PDBP Consortium Meeting 2017

Conference planning and administrative services for the PDBP Consortium Meeting 2017